TROGLITAZONE TREATMENT OF MYOTONIC DYSTROPHY

If troglitazone proves beneficical in improving muscle mass and strength and decreases insulin resistance, it will be important ot pursue future studies to evaluate its usefulness as a synergistic therapy with growth hormone or insulin- like growth factor 1, as well as further studies to determine its longer term beneficical effects as monotherapy.